Columbia Integrated Training Program in Infectious Diseases Research

PROJECT ABSTRACT
This is a renewal application from the Columbia University Irving Medical Center (CUIMC) for a post-doctoral
training grant in Infectious Diseases entitled “Columbia Integrated Training Program in Infectious Disease
Research (TP-IDR)”. Drs. Anne-Catrin Uhlemann and Magdalena Sobieszczyk will serve as principal
investigators (PIs) under the multiple PI NIH model. Both are established investigators with complementary
research interests and longstanding commitments to the training of new investigators. The goal of this proposal
is to train post-doctoral fellows with MD or MD-PhD degrees who are destined for academic infectious disease
careers. The interdisciplinary program is designed to provide the necessary skillset to successfully pursue
translational research whether this research be primarily basic, implementation science or
clinical/epidemiological. The dramatic advances in the fields of microbial genomics and biomedical informatics
and the potential application of these rapidly evolving tools to translational research has necessitated a
reappraisal of our approach to training new investigators. The ongoing recruitment to CUMC of world class
investigators (e.g., Dr. David Ho, Aaron Diamond AIDS Research Center in Division of Infectious Diseases; Dr.
Megan Sykes, Center for Translational Immunology) combined with pre-existent strengths in Infectious
Diseases, pathogen discovery (Dr. Ian Lipkin, Center for Infection and Immunity), Biomedical Informatics (Dr.
George Hripcsak) and retroviral-host protein interactions (Dr. Stephen Goff, Howard Hughes Medical Institute)
has allowed us to construct a Training Program that can recognize and nurture talented individuals. The TP-IDR,
is not only producing new investigators but is also stimulating new interest in Infectious Disease research more
broadly at CUIMC. Resubmission is being sought to continue the success demonstrated thus far and to secure
its future. Drs. Uhlemann and Sobieszczyk will continue to co-chair the Executive Steering Committee that serves
as the governing body. A Diversity Enhancement and Recruitment and Selection Committees will insure that
our applicant pool is strong and diverse. A dynamic mix of well-established and junior investigators has been
assembled to form a close-knit, dedicated faculty. Trainees selected to the TP-IDR have a choice of laboratory-
based, health disparities/ implementation science, or clinical/epidemiological-based research projects and have
the option of obtaining a Master’s degree in either Epidemiology or Biomedical Informatics. Didactic conferences
and integrated TP-IDR seminars complement the educational experience. Mentorship, training, career
development and feedback are thorough. An Advisory Committee, including members from within and outside
the institution, will assist with oversight of the program. Institutional support is strong and broad-based. The
intersection of microbial genomics, biomedical informatics and pathogenesis with clinical investigation,
translational research, implementation science, epidemiology and global health form the conceptual vision of the
TP-IDR. This program permits us to train the academic Infectious Disease leaders of the future.

Public health relevance
PROJECT NARRATIVE This is an application for a renewal from the Columbia University Irving Medical Center (CUIMC) for a post- doctoral training grant entitled the “Columbia Integrated Training Program in Infectious Disease Research” (Drs. Anne-Catrin Uhlemann and Magdalena Sobieszczyk, principal investigators). The goal of this proposal is to train postdoctoral fellows with MD or MD-PhD degrees in state-of-the-art infectious disease research technologies and information handling. This interdisciplinary program will provide trainees with the necessary skillset to become leaders in the field of Infectious Diseases and thereby be in position to meet the infectious disease threats of the future and protect the public health.